Mechanistic characterizations of redox regulations and functions of Arf and Rho families

Project Summary:
Arf and Rho small GTPases play critical roles in cellular functions. They cycle the active GTP- and inactive
GDP-bound forms. They possess their own unique redox-sensitive motifs. However, the redox regulations and
functions of their redox motifs are unknown. Without knowing them, the development of effective therapeutics
for diseases associated with them is impractical. The objective of the parental project is to understand the
redox-dependent regulations and functions of these proteins. The long-term objective of the parental project is
to develop therapeutic interventions for these diseases. This objective includes the identification of novel
redox-inert nucleotides that seem to target the redox-sensitive Arf and Rho proteins to block their redox
responses.
To achieve these goals, the parental grant proposal proposed characterizations of the previously unknown
redox-sensitive motifs found in the Arf family of proteins. A multidisciplinary study that uses EPR and
fluorescent spectroscopic and mass spectrometric approaches, as well as mutagenesis-based redox
biochemistry with novel mechanism-based nucleotide analogs and cell biology methods, was proposed. While
the proposed spectroscopic approaches can identify the proposed key intermediates, including thiyl radicals,
the predicted resultant formation of the GDP adduct in Arf and Rho GTPases cannot be directly monitored.
Also, the method to monitor the formation and decay of the proposed Tyr radical in Rho GTPase was
unspecified in the parental grant proposal. Our preliminary studies indicate that the GDP adduct can be
detected using UV/Vis spectrophotometric analysis. The Rho Tyr radical can also be monitored by a UV/Vis
spectrophotometer. Therefore, we propose to add UV/Vis analysis to the parental grant proposal. Accordingly,
we request a fund to obtain a UV/Vis spectrophotometer that is capable of the detection of the GDP adduct and
the formation and decay of the Tyr radical.
The additional characterizations obtained through mutagenesis-based redox biochemistry and cell biology,
as well as other spectroscopic methods, will identify the various unprecedented redox intermediates, allowing
one to characterize the regulatory features and redox response properties of the redox-sensitive motifs found in
Arf and Rho GTPases. Furthermore, the redox biochemical analysis of this multidisciplinary approach includes
the use of nucleotide analogs that are novel redox-inert nucleotides. The UV/Vis spectrophotometer can also
monitor changes in the state of novel redox-inert nucleotides in Arf and Rho GTPases. Thus, the use of the
UV/Vis spectrophotometer will not only allow an examination of the mechanisms underlying the actions of
these redox motifs in the small GTPases, but it will also provide light on a novel therapeutic approach wherein
diseases associated with the uncontrolled redox response of these motifs in the small GTPases are reduced or
eliminated through redox desensitization of these motifs.

Public health relevance
Project Narrative: This application seeks funding for a UV/Vis spectrophotometer in order to add critical UV/Vis spectrophotometric data to the parental study plan. The parental study aims to research the processes underlying the redox-mediated activations of Arf and Rho GTPases and to explore the therapeutic effects of novel redox-inert nucleotide analogs that desensitize the redox response of these small GTPases. The addition of the UV/Vis spectrophotometric approach will aid the discovery of the redox-inert desensitizer drugs that may lead to a molecular and mechanistic basis for developing therapies for immune disorders and other relevant diseases associated with the uncontrolled redox functions of these small GTPases.